A PHASE IB TO EVALUATE SAFETY AND TOLERANCE OF MULTIPLE DAILY IV RSR13 INFUSIONS

To establish the safety and tolerance of multiple daily intravenous infusions of RSR13 administered with supplemental low flow oxygen immediately prior to radiation therapy. Determine the pharmacokinetic/pharmacodynamic profile of multiple daily intravenous infusions of RSR13 administered with supplemental low flow oxyen immediately prior to radiation therapy.